Relapse to drug-seeking behavior is regulated by medial habenula NR4A2 in male and female mice

Project Summary/Abstract
Substance use disorder is complicated by a lifelong risk of relapse. Relapse vulnerability is programed partly
during drug use, when the action of drugs of abuse in the reward circuit enables the formation of abnormally
strong context/reward memories. These memory processes underlie common relapse triggers such as exposure
to drug-associated cues or environments and can be extremely long lasting. This persistence may be attributed
to epigenetics (i.e. modulation of gene expression that occurs through altered chromatin structure without
fundamental changes to the DNA sequence itself), which has been shown to establish stable changes in cell
function, and in turn changes in behavioral outcomes. This proposal is focused on examining the molecular and
cellular mechanisms that may be involved in reinstatement. Recent studies have begun to implicate the MHb in
cocaine-associated behaviors, yet the role of the MHb in regulating reinstatement of cocaine self-administration
remains largely unknown. Recent work in the lab has identified the histone deacetylase 3 (HDAC3; a powerful
epigenetic regulator of gene expression) target gene, Nr4a2, as an important regulator of cocaine-associated
behavior. NR4A2 is a transcription factor that regulates aspects of dopamine signaling during development, and
is densely expressed in the MHb. I will test the central hypothesis that the MHb regulates reinstatement of
cocaine self-administration in an NR4A2-dependent manner. Specifically, I will examine the role of Nr4a2, in
MHb-dependent reinstatement of cocaine self-administration using viral expression of NURR2C, an
endogenously occurring NR4A2 dominant negative splice variant, or wild-type NR4A2 to bidirectionally regulate
NR4A2 function. My preliminary data show that NURR2C animals have reduced reinstatement, identifying
NR4A2 in the MHb as a key regulator of reinstatement behavior. To develop a more in-depth understanding of
the MHb response to cocaine-seeking behavior as well as self-administration, extinction training, and withdrawal,
I will use single nuclei RNA sequencing to look for changes in cell type proportions, gene expression and gene
networks. Within these analyses I will also look for NR4A2-dependent changes and sex-dependent changes.
Completion of the proposed research will significantly advance our understanding of the MHb in reinstatement,
and provide important insight into NR4A2 and NR4A2-dependent gene regulation. This training fellowship will
allow me to develop molecular and bioinformatics expertise. With the guidance of both Dr. Wood and Dr. Swarup
and the research and professional development environment at UCI, this fellowship will provide a foundation for
a successful career as an independent investigator focused on understanding the molecular mechanisms of
learning and memory that contribute to relapse to drug-seeking behavior.

Public health relevance
Project Narrative Substance use disorder is a chronic relapsing condition that affects over 20 million Americans each year, costing upwards of $700 billion. Drugs of abuse alter the basic function of our reward system by enabling the formation of persistent relapse-triggering cue-reward associations, for which there is no completely effective treatment. This proposal will examine an understudied driver of relapse behavior, the medial habenula, and examine the pivotal role of an important dopaminergic regulator, NR4A2, within this region in a model of cocaine self- administration and reinstatement in male and female mice.